A New Cryo-Transmission Electron Microscope at Thomas Jefferson University

1. Project Summary and Abstract
Cryogenic-electron microscopy (cryo-EM) combined with Single Particle Analysis (SPA) have forever changed
life-science research. Undoubtedly, we have entered the post-crystallography era of structural biology.
However, a drawback of cryo-EM that limits its applicability is the cost of the instrumentation required for high-
resolution data collection. A state-of-the-art Krios 300 kV electron microscope is around 5-7 million USD that
quickly reaches and often exceeds 10 million USD with added costs for renovation, service contract, and
supportive staff. This is not only unaffordable for many universities but also insufficient to establish cryo-EM as
a routine methodology to study biological macromolecules. A considerable part of the cryo-EM SPA pipeline is
spent screening specimens, which includes identifying vitrification conditions and imaging grids. Such an
essential yet time-consuming prep-work can be achieved effectively and perhaps even more efficiently on less-
powerful 200 kV microscopes that are easier to maintain and can be operated by non-experienced users.
Therefore, as part of a cost-sharing plan to establish a state-of-the-art center for electron microscopy at
Thomas Jefferson University (TJU), we request funds to purchase a Thermo Scientific™ Glacios™ Cryo-
Transmission Electron Microscope (cryo-TEM) equipped with Falcon 4 Direct Electron Detector. We
have identified a group of 11 major core users from both inside TJU and in nearby institutions who eagerly
support this proposal. As proof of commitment to establish cryo-EM at TJU, the Provost, Dr. Mark Tykocinski
has agreed to lease the Glacios at zero money down for 12 months with no obligation to buy the
instrument. After the completion of the 12 months, the University can terminate the lease and return the
microscope or extend the lease by making three annual installments or purchase the equipment for cash at the
fair market value. The University has also committed to infusing additional funds to support a yearly service
contract, equipment maintenance fees, and support a recently recruited cryo-EM manager. If funded, this S10
will help defray a significant portion of the cost of the microscope, providing vital economic assistance to the
University at a time of considerable financial uncertainty.
We have opted for the Thermo Scientific™ Glacios™ 200 kV cryo-TEM with Falcon 4 camera, which is
an affordable workhorse that provides an excellent setup for in house cryo-EM. Also, in light of the significant
investment made by NIH to develop synchrotron-like cryo-EM federal facilities around the US, we believe that
acquiring a screening cryo-TEM is a sensible investment for a metropolitan campus. The Glacios expands and
enhances the quality, capability, efficiency, and cost-effectiveness of cryo-EM studies for our researchers and
those at local and regional universities and research centers in the Philadelphia area.

Public health relevance
Cryogenic-electron microscopy (cryo-EM) has recently emerged as a powerful technique in biomedical research that allows scientists to study the atomic structure of macromolecules under quasi-physiological conditions, vital to decipher the mechanisms of disease and develop new potent drugs. Here, we request matching funds to acquire a modern Thermo Scientific™ Glacios™ Cryo-Transmission Electron Microscope equipped with a Falcon 4 Direct Electron Detector. This new microscope will be maintained as a shared resource at Thomas Jefferson University and integrated with the goals of our university, whose primary mission is to improve public health.